CORE--BIOSTATISTICS

The overall objective of this proposal is to seek continuing core giant support to sustain the expanding activities of the Biostatistics Shared Facility (BSF) of the Comprehensive Cancer Center (CCC). The BSF serves as a focal point from which the Center's investigators may draw statistical or epidemiologic expertise for planning, management and analysis of their studies. It also develops, tests and implements various techniques of data management and statistical analysis, including mathematical modeling, applicable to cancer research. The specific aims of the Biostatistics Shared Facility are to: (l) coordinate and manage statistical activities in the Cancer Center to ensure that investigators have ready access to statistical consultation and support; (2) provide statistical expertise in study design including research proposal development, sample size determination and power calculation, randomization procedures, data collection form design, and plans for interim reviews and final analysis; (3) develop and manage cancer related research databases to serve as a multidisciplinary research resource for CCC investigators; (4) provide statistical analysis for CCC projects using up-to-date statistical and computing methodologies; (5) provide epidemiologic expertise in study planning and analysis for the CCC investigators, primarily in the area of cancer prevention and control research; (6) maintain a computing facility with up-to-date software for data management, statistical analysis, and network communications that is available to CCC members; (7) provide training opportunities and education in biostatistics to graduate students, oncology residents, fellows and CCC investigators regarding the applications of statistical principles to cancer research; and (8) perform statistical methodology research pertaining to practical application in cancer research. The BSF will be operated under the specific usage policies and priority guidelines established with the advice of its Advisory Committee.